Molecular mechanisms of tumor response to cytotoxic chemotherapy

The long-term objective of this project is to understand mechanisms of tumor response to cytotoxic chemotherapy. We will examine the hypothesis that hypoxia inducible factor genes play key roles in determining tumor responses to cytotoxic cancer therapy. We will conduct experiments to characterize cytotoxic chemotherapy-induced HIF-1 and HIF-2 gene activation in murine tumor models using novel molecular imaging approaches. We will examine the roles of specific nitric oxide synthase genes in chemotherapy (cyclophosphamide and etoposide)- induced HIF-1&2 activation (Specific aim 1). We will also make efforts to define the molecular mechanism through which nitric oxide mediates therapy-induced HIF-1&2 activation in cytotoxic chemotherapy therapy (Specific aim 2). In addition, we will evaluate the roles of HIF genes in cancer response to chemotherapy the genetic approaches (Specific Aim 3).

Public health relevance
PROJECT NARRATIVE This project studies the mechanism of the involvement of the HIF genes in chemotherapy treatment of solid tumors. It may provide new insights that allow for the development of new therapeutics that can enhance current treatments for cancer. __SpecificAimsTextDelimiter__ RESEARCH PLAN A. SPECIFIC AIMS Hypoxia is a common feature of all solid tumors. There has been increasing evidence to indicate that hypoxia plays an important role in tumor development and prognosis. Hypoxia inducible factor (HIF) genes play central roles in mediating molecular and cellular response to hypoxia. Recent studies have highlighted the importance of the HIF genes in mediating cellular response of solid tumors to cytotoxic therapies. In this project, we propose to examine a novel biological hypothesis that, if proven true, may significantly improve solid tumor chemotherapy. Our hypothesis is that HIF-1&2 factors play key roles in determining solid tumor responses to cytotoxic chemotherapy, and that attenuation of HIF-1&2 levels can enhance the efficacy of such therapies. Our project is based on previous studies indicating that hypoxia and related HIF-1&2 factors play important roles in determining prognosis of tumors in response to chemotherapy. In addition, it is based on our recent discovery (see preliminary data section and attached reprint) that indicated HIF factors were activated by cytotoxic therapy independent of hypoxia and played important roles in tumor survival after therapy. The long-term objective of this project is to characterize the status of hypoxia inducible factors (HIF) during cytotoxic chemotherapy of solid tumors and to exploit such knowledge for therapeutic gain. To achieve this objective, we will have the following specific aims: Specific aim 1. To investigate the roles of nitric oxide synthases in chemotherapy-induced HIF-1&2 activation. Our previous work has indicated cytotoxic chemotherapy can induce HIF-1 activation through a nitric oxide-mediated mechanism (see appendix 1 and preliminary data). In this specific aim, we will carry out in-depth studies to examine the influence of nitric oxide on chemotherapy-induced HIF-1 and HIF-2 activities by use of state-of-the-art molecular imaging technology in combination with various cellular and animal models. Specific aim 2. To define the molecular mechanisms of chemotherapy-induced, nitric oxide-mediated activation of HIF 1&2. In previous studies, we have shown that during radiotherapy and cytotoxic chemotherapy, nitric oxide activates HIF-1 by stabilizing HIF-1α through S-nitrosylation. In this aim, we will make effort to further define the molecular pathways through which nitric oxide stabilizes HIF-1α or HIF-2α. Specific aim 3. To evaluate the importance of HIF-1&2 activation on tumor survival during cytotoxic chemotherapy. In this specific aim, we will carry out experiments to determine if inhibiting HIF-1&2α activation is an effective strategy to enhance cytotoxic chemotherapy of solid tumors. We will use combined shRNA knockdown (for HIF-1&2α in tumor cells) and cre-lox based conditional genetic knockout approaches (for HIF-1&2α in host mice) to dissect the importance of HIF-1α and HIF-2α in tumor vs stromal cells. Upon completion of the proposed study, we expect to gain significant mechanistic insights into the roles of HIF- 1 and HIF-2 factors in cytotoxic therapy of solid tumors. Such insights should allow us to determine if HIF inhibition is a feasible strategy to enhance current solid tumor chemotherapy.